Improving alcohol and substance use care access, outcomes, and equity during the reproductive years: A Type 1 Hybrid Trial in Family Planning Clinics

Rates of risky alcohol and drug use and alcohol and substance use disorders (AUDs/SUDs) are highest among
women during their reproductive years compared to other periods of the life course. AUDs and SUDs are
associated with significant and lifelong behavioral, mental, physical, and sexual and reproductive health (SRH)
consequences for women and disproportionately for racially and ethnically minoritized women and those living
in poverty. There is an urgent need for innovative methods to address alcohol and substance use in preventive
healthcare settings. Family planning (FP) clinics are a trusted care source and primary point of access for
women and serve as a safety net for structurally marginalized groups in the U.S. FP clinics are uniquely well-
suited, but entirely understudied, contexts for implementing and scaling integrated alcohol/drug use services.
While screening, brief intervention, and referral to treatment (SBIRT) is a widely accepted, evidence-based
intervention for alcohol use in primary care and mental health settings, little is known about the facilitators and
barriers to the uptake and sustainment of SBIRT in FP clinics. Even less is understood about telemedicine,
which has been rapidly rolled out for COVID-19, as a SBIRT delivery platform. Further, virtually no evidence
exists on effective organizational level implementation strategies to accelerate SBIRT’s adoption in FP.
We propose an explanatory, sequential, mixed methods study to evaluate SBIRT in an expansive FP
clinic network of a national SRH organization – a novel and highly impactful setting with a reach of a diverse
and largely socially disadvantaged population of reproductive-aged women at greatest risk for AUDs/SUDs.
Our integrated study draws upon the evidence-based implementation approach, Implementation and
Sustainment Facilitation (ISF), guided by the Consolidated Framework for Implementation Research and
Reach, Effectiveness, Adoption, Implementation and Maintenance models. In Aim 1, to identify specific targets
for implementation, sustainment, and scale-up of SBIRT, we will conduct administrative surveys with clinic
stakeholders (clinic directors, providers, and staff n=153) and key informant interviews with stakeholders and
patients (n=40) to investigate organizational practices and perspectives on alcohol- and substance-related
services. In Aim 2, we will conduct a dual randomized Type 1 Hybrid Effectiveness-Implementation trial testing
SBIRT (in-person and telemedicine) vs. usual care, within a large, high-volume Northeastern affiliate of the
national organization. We will randomize 600 patients across 4 clinics, collecting patient level data on alcohol
and substance use primary effectiveness outcomes, as well as secondary SRH, mental/physical health, quality
of life, and wellbeing outcomes at baseline, 30 days, and 3 months. Aim 3 will explore facilitators and barriers
to SBIRT adoption and the ISF implementation strategy via surveys and interviews with clinic directors,
providers, and staff (n=20) and patients (n=20) electronic medical records. Results will provide new, timely
evidence to inform scale-up of alcohol and substance related services in FP settings nationally.

Public health relevance
Alcohol and other substance use disorders in reproductive-aged women are of great public health relevance given their association with significant and lifelong adverse physical, mental, and sexual and reproductive health consequences, especially for the most structurally marginalized groups in the U.S. There is an urgent need for new settings and innovative methods to address risky alcohol and substance use in preventive women’s health care contexts in order to improve interrelated health outcomes and equity across the reproductive life course. This implementation trial will evaluate family planning clinics as a novel setting in which to simultaneously test the effectiveness of screening, brief intervention, and referral to treatment (SBIRT) for alcohol and drug use. Coupled with an evidence-based Implementation and Sustainment Facilitation implementation strategy, our findings will ultimately support adoption and scale-up of substance-related care across a premier national sexual and reproductive healthcare organization and its expansive network of FP clinics serving millions of women in the U.S. every year.